Development of advanced glycation end product (AGE)-breaking enzymes as a novel therapy for the treatment of diabetic retinopathy

PROJECT SUMMARY
Diabetic retinopathy (DR) is a major complication associated with Type 1 and Type 2 diabetes. Approximately
20% of patients with diabetes develop DR. DR is the leading cause of blindness in the working age population
(20-74 years old) and affects more than 6.6 million adults in the U.S. alone. Existing therapies primarily target
vascular hyperpermeability, which is responsible for intraocular pressure increase and visual disturbances.
While antibodies against VEGF (ranibizumab, aflibercept), have shown clinical benefit and are now widely
used for DR treatment, only 50% of patients with diabetic macular edema receiving anti-VEGF treatment have
appreciable clinical benefit. This underscores the need for better treatments that address the upstream
pathology and can provide treatment for both forms of DR including those refractory to anti-VEGF therapy.
Current FDA-approved treatments do not address pathogenic mechanisms driving the disease.
The pathophysiology of DR is related to prolonged exposure to high blood sugar, leading to non-specific
glycation of proteins and subsequent formation of toxic advanced glycation end-products (AGEs). Evidence
suggests that accumulation of AGEs play a role in the vascular and inflammatory complications associated
with diabetes, including DR. Revel Pharmaceuticals has developed a novel class of therapeutics designed to
cleave one of the most significant AGEs present in the eye, carboxymethyl-lysine (CML), thus removing a
significant driver of DR.
Our goal in this Phase I grant is to optimize lead drug candidates and demonstrate enzyme activity on
physiologically relevant DR substrates. Our specific aims are to (1) engineer CML oxidase to efficiently cleave
CML modifications from physiological substrates (2) characterize CML oxidase activity on human retinal tissue.
Successful completion of this Phase I SBIR project will yield the first therapeutic enzyme designed to remove
and repair AGE damage in vivo. In Phase II, we will carry out in vivo efficacy and IND-enabling studies with our
collaborators at Vanderbilt Ophthalmic Contract Research Organization (VO-CRO) to support an IND
submission.

Public health relevance
PROJECT NARRATIVE Diabetic retinopathy (DR), the leading cause of blindness, results from high blood glucose damaging the blood vessels in the retina. This damage includes glycation of matrix proteins like collagen, which results in accumulation of advanced glycation end products (AGEs), triggering vascular dysfunction, permeability, and inflammatory signaling. Revel Pharmaceuticals is developing a novel class of therapeutics designed to enzymatically cleave AGEs thus removing a significant driver of DR.